Multimodal Musical Stimulation for Healthy Neurocognitive Aging

Abstract
Music that we encounter every day contains amplitude and frequency modulations,
rapid changes in acoustic signals that convey meaningful information to the listener.
The human brain’s ability to receive and interpret meaning from these signals is
implemented by networks of neural oscillations: firing patterns of groups of neurons that
track the music with rhythmic activity. Neural oscillations in different frequency bands
subserve attention and memory, as well as perception and comprehension; they
develop over the lifespan and are reduced in aging, especially in dementia. Being able
to understand and causally control neural oscillations will have crucial implications for
healthy neurocognitive aging. Since music naturally stimulates the brain with its
rhythmic content over time, we hypothesize that music can be used as a sustainable,
naturalistic form of brain stimulation to induce oscillatory in neuronal populations.
Furthermore, we hypothesize that by inserting gamma-band energy as sensory
stimulation during music listening, we can increase gamma-band activity in the brain in
a way that is frequency-tuned to the brain’s intrinsic network dynamics, thus replacing
the decreased neural oscillations that are reduced in aging, and improving memory and
cognition in older adults. We hypothesize that gamma-band modulations inserted in
lights, when coupled with music listening, can improve memory in older adults by
frequency-tuning to intrinsic individual brain network dynamics. Here we propose the
first randomized, double-blind, placebo-controlled feasibility study, to test the effects of
music-coupled gamma-band stimulation on EEG and behavioral indices of working
memory in older adults. Results will test the causal role of oscillatory mechanisms of the
brain on cognition. If successful, this trial will lay the groundwork to the first musical,
neurophysiologically targeted, brain-stimulation device for reversing cognitive decline in
aging.

Public health relevance
Project Narrative We propose a Stage I randomized, sham-controlled trial on the effects of multimodal musical stimulation on working memory in aging. Neurologically healthy older and younger adults will be tested on working memory and electroencephalography in the first randomized controlled trial of music as a form of brain stimulation, with multimodal musical stimulation and control stimulation conditions. Results will test the causal role of oscillatory mechanisms of the brain on cognition, and will lay the groundwork to the first musical, neurophysiologically targeted, brain-stimulation device for reversing cognitive decline in aging.